Targeting Cancer at the Protein-Membrane Interface

Project Summary
Significant progress in human cancer therapy in the last decade has been driven by conceptionally new
approaches to treating cancer, including cancer immunotherapy, cancer nanotherapy (e.g. liposomal doxorubicin
or mRNA vaccines), or new types of biologics and small molecules. I propose to develop new approaches to
targeting protein-membrane interactions that could yield unprecedented methods to modulate cancer signaling
and generate useful paradigms for pharmacology at large. The role of protein-membrane and drug-membrane
interactions will be explored and targeted on various levels, each highly relevant to cancer pharmacology:
1. Cancer signaling, a hallmark of cancer, is largely dependent on the recruitment of kinases (e.g. PI3K or PKC)
and GTPases (e.g. RAS) to hotspots localized at the inner plasma membrane leaflet. I aim to develop bifunctional
inhibitors with the capacity to modulate these interactions as a new approach to target cancer signaling.
2a. Membrane-integrated receptors are also key players in cellular signaling (e.g. enzyme-linked receptors or
GPCRs). Recently, a number of pharmacophores have been discovered that target these proteins directly from
the intramembrane space. These `Intramembrane pharmacophores' first partition into the membrane and then
engage their target through lateral diffusion and entry. I aim to systematically modulate membrane exposed
pharmacophore sites to explore principles governing the action of these pharmacophores which in turn will aid
in the discoveries of new intramembrane pharmacophores.
2b. The majority of bioactive molecules acts on membrane proteins or intracellular targets and therefore needs
to partition into or cross biological membranes. I propose to use combinatorial chemistry to discover new
principles and chemical structures that modulate and privilege pharmacophores for cellular uptake. These will
be tested in live cells using high throughput assays as a holistic approach to covering all possible uptake
mechanisms on the first level of screening (e.g. endocytosis, transporters, passive diffusion).
Combined, the proposed research will provide important insights into the functional role of protein-
membrane interactions in cancer signaling and their vulnerability to small molecule-based modulation.
Each of the proposed directions has the potential to yield fundamentally new and unprecedented
approaches to targeting cancer and other diseases.
My mentor and collaborators have extensive experience in cancer pharmacology, drug discovery, and the
biophysical characterization of protein-membrane interfaces and will provide the training needed to conduct the
proposed research. They will also provide the mentorship needed to acquire all skills and preliminary data
needed for a successful transition to an independent career in cancer research.

Public health relevance
Project Narrative The goal of this proposal is the development of fundamentally new and more effective approaches to cancer therapy and disease pharmacology in general that will complement and enhance existing therapies. This project will develop new pharmacophores with the capacity to target the interactions between proteins and membranes directly, explore the modulation of binding properties at the protein-membrane interface, and screen for new principles governing cell permeability of small molecules which is a fundamental requirement for the bioactivity of most drugs. Combined, these approaches will create new classes of pharmacophores and methods to address cancer signaling (e.g. KRAS, PI3K, PCK etc), membrane-integrated targets (GPCRs, ion channels, enzyme- linked receptors, transporters etc.), and soluble intracellular targets at large.